Centella asiatica effects on neuroinflammatory responses in Drosophila models of acute inflammation and aging

PROJECT SUMMARY
Aging is characterized with dysregulated immune function contributing to the decline in biological resilience and
increasing vulnerability to death. Aging individuals develop inflammaging, a state characterized by elevated
levels of inflammatory cytokines, which contribute to the increase in chronic morbidity, frailty and lead to
deterioration of neurological and functional resilience in the elderly. There are no approved interventions
currently available to counteract the deleterious effects of inflammaging. Certain lifestyle modifications such as
regular physical activity, calorie restriction and plant-based diet have been associated with decreased levels of
chronic inflammation resulting in slowed biological aging. Numerous botanical dietary supplements are currently
available on the market with claims to improve resilience to age-related deterioration in cognition, sleep or mood.
However, the molecular mechanism of action for most of these formulations remains unknown. The BENFRA
Botanical Dietary Supplements Research Center at OHSU has been involved in evaluating the potential of the
Ayurvedic plant Centella asiatica (gotu kola) in alleviating age-related neurological changes. The research
performed at the center has demonstrated that hot water gotu kola extract (CAW) has positive effects on
antioxidant response, mitochondrial activity and synaptic health in both in vitro and in vivo preclinical mouse
models. However, the previous research at the BENFRA center has not assessed the potential of standardized
CAW extract to reduce brain specific inflammation in in vivo models of aging or acute neuroinflammation.
In this application we propose to test the ability of CAW to ameliorate acute and age-related
neuroinflammation in the genetically tractable organism Drosophila melanogaster. Similar to mammals,
transcription of pro-inflammatory molecules in Drosophila is mediated by the evolutionarily conserved
transcription factor NF-κB, whose activity also increases with age. Here, we will evaluate the effects of CAW on
neuroinflammation in aging wild type Drosophila, in Drosophila with constitutively active innate immune system
undergoing accelerated aging, and in a Drosophila model of Paraquat (PQ)-induced oxidative stress. In each
model, using optimized CAW feeding regimens, we will assess survival, the levels of brain-specific inflammatory
gene expression or oxidative stress markers. Moreover, we will test the effects of CAW on neurological outcomes
by measuring mobility behavior and vacuolar neuropathology in brain tissue. This research will verify whether
CAW lowers levels of inflammation in in vivo models of acute neuroinflammation and aging, and if it ameliorates
associated neurological phenotypes. A demonstration that CAW can affect inflammaging will serve as the basis
of including biomarkers of inflammation as important endpoints in future clinical trials of CAW.

Public health relevance
PROJECT NARRATIVE The low grade chronic inflammation, which accompanies human aging (inflammaging), is thought to contribute to age-dependent decline in biological resilience and constitutes a major risk factor for chronic diseases in the elderly. This proposal will attempt to decipher the protective mechanistic effects of the hot water extract of Centella asiatica (CAW) formulated by the BENFRA Center at OHSU on acute and chronic inflammation in the genetically tractable organism Drosophila melanogaster to promote healthy aging.